Intracellular signaling dynamic control of synaptic responses in the basal ganglia

Project Summary
The external globus pallidus (GPe) is a central hub nucleus that processes information necessary for
behavioral control by the basal ganglia, a group of interconnected forebrain nuclei. A wide range of behavioral
disorders, including the formation of obsessive and compulsive habits, and the generation of psychotic, major
depressive, and anxiety disorders are all thought to arise by dysfunctions of the basal ganglia because these
nuclei process a wide range of information. Sensorimotor, associative, and cognitive information from many
regions of the cortex and thalamus are integrated by projection neurons of the striatum, the main basal ganglia
input nucleus. In order for the basal ganglia to control behavior, information from the striatum must then be
integrated by the GPe. In the rodent, where the connectivity of the basal ganglia is best quantified, millions of
striatal projection neurons (SPNs) form hundreds of millions of inhibitory synapses on only tens of thousands
of GPe neurons. Each GPe neuron has two unique properties that may allow them to process an enormous
amount of information: long dendrites and spontaneous somatic firing. The long dendrites of GPe neurons
allow them to receive an enormous number of inhibitory striatal synaptic inputs, but also force these inputs
to propagate along the dendrites before they can be integrated by the somata as changes in firing. The
spontaneous firing of GPe neurons is driven by intracellular second messengers that activate two protein
kinases that can enhance dendritic propagation. The goal of this proposal is to investigate how dendritic
protein kinase activity (1) relates to the spontaneous firing activity of GPe neurons and (2) controls their
integration of inhibitory striatal synaptic inputs. To address these questions, this proposal is divided into
two aims. (Aim 1) Determine the relationship between dendritic protein kinase activity and spontaneous firing
activity in GPe neurons. I will receive training in two-photon fluorescence lifetime microscopy to measure the
spatiotemporal dynamics of dendritic protein kinase activity, while simultaneously measuring the
spontaneous firing activity of GPe neurons using the cell-attached technique. (Aim 2) Determine how protein
kinase activity controls the spike time responses of GPe neurons to dendritic input from the striatum. I will
receive training in laser scanning photostimulation to selectively evoke dendritic striatal inputs, and will
employ perforated patch clamp recordings to measure the effect of blocking protein kinase activity on the
integration of these dendritic inputs. The proposed work will advance our understanding of information
processing within the basal ganglia and will broaden my research approach. I will perform the proposed work
under the mentorship of Dr. Tianyi Mao, a pioneer in the design and use of optical techniques to measure the
spatiotemporal dynamics of protein kinase activity and the integration of dendritic synaptic inputs, at the
Vollum Institute, a world-renowned research institute that has advanced our understanding of synaptic
transmission and intracellular effector functions for the past four decades.

Public health relevance
Project Narrative The external globus pallidus (GPe) is the central information hub of the basal ganglia, a collection of forebrain nuclei whose dysfunction is thought to generate obsessive-compulsive, psychotic, major depressive, and general anxiety disorders. This proposal will investigate the mechanisms by which the dendrites of GPe neurons integrate convergent information from the striatum, the main basal ganglia input nucleus. Elucidation of these mechanisms will contribute to our fundamental knowledge of information processing within the basal ganglia and inform therapeutic approaches that seek to reduce the symptoms of psychological disorders.